Multi-Axis 3D Bioprinting of Cardiac Tissues with Ventricular Helical Alignment

PROJECT SUMMARY/ABSTRACT
Congenital heart disease (CHD) affects over 12 million people globally and contributes to over 260,000 deaths
each year. Among the most severe forms of CHD are single-ventricle heart defects, characterized by an
underdeveloped or absent ventricle. Palliative repair for single-ventricle cardiac anomalies consists of a staged
surgical approach culminating in the Fontan procedure, wherein the functioning ventricle is committed to
supporting systemic circulation while venous return is routed passively to the lungs through a synthetic
extracardiac graft without direct pump support. Although the Fontan procedure facilitates initial survival, patients
experience significant long-term comorbidities due to the absence of a subpulmonary ventricular pump,
ultimately leading to heart, liver, or other organ failure. One potential solution to this problem is to engineer a
contractile cardiac conduit to replace the passive synthetic extracardiac graft, providing a second ventricular
pump that can shift the univentricular Fontan circulation towards a more stable biventricular physiology. The
Feinberg lab has recently demonstrated the use of Freeform Reversible Embedding of Suspended Hydrogels
(FRESH) 3D bioprinting to produce cardiac pumps with synchronous contraction and pressure generation;
however, these pumps have not achieved the contractile pressure generation necessary to serve as a substitute
ventricle in the Fontan circulation. This limitation is likely due to the lack of a helical myocardial architecture,
which has been shown in the adult ventricle to drive systolic ejection fraction through ventricular torsion and wall
thickening. I hypothesize that cardiac conduits bioprinted with biomimetic helical architecture will demonstrate
improved contractility and pressure generation similar to the native right ventricle (>15mmHg). In Aim 1, I will
develop a novel multi-axis nonplanar printing platform that provides additional degrees of movement, allowing
for precise deposition and alignment of material in biomimetic helical architectures. I will validate this technology
by fabricating collagen conduits with varying circumferential and helical alignments and performing mechanical
characterization to evaluate how fiber orientation affects biomechanical properties. In Aim 2, I will bioprint a
contractile cardiac conduit with ventricular helical alignment and assess the construct for functional performance
and contractility. The findings of this proposal will establish a scalable platform for engineering contractile cardiac
tissues with native-like architecture and function, laying the foundation for future efforts to fabricate organ-scale
cardiac constructs for organ transplantation.

Public health relevance
PROJECT NARRATIVE Current methods for palliative repair of single-ventricle heart malformations often lead to life-long comorbidities associated with the lack of a subpulmonary ventricular pump, committing patients to a state of chronic circulatory inefficiency progressively eventuating in heart, liver, and other organ failure. This proposal aims to bioengineer a functional biological cardiac conduit with improved contractility and pressure generation by leveraging a novel multi-axis nonplanar printing platform to recapitulate ventricular helical myocardial architecture. Completion of this work will be an important step towards engineering regenerative cardiac tissues capable of effectively replacing the missing ventricular pump in single-ventricle patients.